Patient Priorities Survivorship Care for Older Women with Breast Cancer

PROJECT SUMMARY/ABSTRACT
Although older women derive a similar degree of benefit from breast cancer survivorship
guidelines as their younger counter-parts, there are other issues such as multiple medical
comorbidities and unique care needs that may impact survivorship outcomes. The frequent
interactions with the health system and clinician visits, negotiating conflicting information about
symptoms and treatments, adapting recommendations into daily routines, managing
medications can increase the treatment burden experienced by older women with breast
cancer. Currently, there are no available approaches to guide patients in considering the
complexity of shifting from managing a potentially life-limiting disease to managing multiple
chronic conditions along with cancer survivorship needs. The literature supports that when older
women with breast cancer learn about their healthcare priorities, they engage more in the
treatment decision-making process. In the proposed project, I will use a Patient Priorities Care
framework to explore older breast cancer survivors' priorities and health care preferences for
high-quality breast cancer survivorship. The framework will include two components: (1) a
health priorities identification session with a facilitator, and (2) an encounter with the oncology
provider to discuss changes in the patient's care plan to align it with his/her priorities. My overall
hypothesis is that prioritizing patients' priorities is feasible and facilitates individualized
survivorship care for older women with breast cancer and multiple chronic conditions. An
advisory panel composed of oncologists, geriatricians, and patient advocates will provide
regular feedback throughout the refinement and adaptation of the Patient Priorities Care
framework to the breast cancer survivorship context and engage in an iterative process of
development. After incorporating feedback from the advisory panel to create an adapted version
of the framework, we will carry out a quasi-experimental pilot study with the objective of
evaluating the feasibility of using the framework in the Oncology clinic and provide empirical
estimates of treatment effect sizes by measuring treatment burden and quality of life at 3
months, adherence to basic and priorities driven survivorship care recommendations at 12
months. Ultimately, the results of this project will provide initial direction of intended
improvement which will be verified in a larger powered future trial. Furthermore, through my
work on this project and the proposed training activities, I will strengthen my skill-set in decision-
making, qualitative/mixed-methods methodology and clinical trial design which will allow me to
transition to my long-term goal of becoming an established independent investigator.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on adopting a patient- priorities approach to decision making during survivorship care for older women with breast cancer and multiple chronic conditions. If shown to be feasible and acceptable to patients and clinicians, this approach maximizes benefits that matter to older women with breast cancer while minimizing harm and burden. This research is relevant to the NIA's mission because of its focus on care for older adults driven by patient's values, goals, and preferences, while supporting the further training of Dr. Giza to become a leader in geriatric oncology care.